CELLULAR DEFECTS IN PAROXYSMAL NOCTURNAL HEMOGLOBINURIA

Currently we are focusing in our PNH studies on identifying the earliest bone marrow progenitor cell on which the PNH phenotype first appears in the marrow.